Rewiring the myeloid cell response to adjuvants to improve tumor control

The critical preliminary data for this proposal is that contrary to the accepted dogma, following exposure to
endogenous immune adjuvants MyD88 delivers a negative signal to macrophages that limits tumor control by
radiation therapy. We demonstrate that in poorly immunogenic tumors, macrophages are rewired following
exposure to dying cancer cells such that they suppress multiple features of the tumor immune environment.
This includes the ability of T cells to control residual disease, and dendritic cell maturation. The aim of this
proposal is to understand the mechanisms by which this suppression occurs, identify the regulation of
macrophage suppression, and use this to identify patient populations that will respond poorly to current
therapies. We hypothesize that exposure to dying cells rewires macrophage signaling such that innate
activation of MyD88 suppresses local tumor immunity. The specific aims of this study are to 1: Test the
hypothesis that loss of MyD88 prevents NFKB driven-anti-inflammatory gene transcription and results in
increased IRF3 driven IFN transcription; 2: Test the hypothesis that signaling through Mertk-mediated ‘rewiring’
of macrophages changes the response to adjuvants limiting immune function in the tumor environment; and 3:
Test the hypothesis that MyD88 patterns of gene expression are linked to poor patient outcome. Our study
design incorporates CT-guided radiation therapy of multiple authentic pancreatic tumor models and using a
range of RT doses and fractionations. These are combined with unique knockouts and assays that allow us to
identify divergent myeloid responses in vitro and in vivo. Our analyses of clinical samples use high quality
bioinformatic approaches that allow us to evaluate effect of the tumor environment on the biological response
to innate adjuvants in patient samples.

Public health relevance
Macrophage suppression of T cell responses in the tumor immune environment represents an important problem limiting cure of residual disease following radiation therapy. We use high quality preclinical models of radiation therapy and immunotherapy to understand the mechanisms of success and failure in myeloid suppression of the T cell control of tumors. This is combined with analysis of clinical samples to explore how a novel mechanistic interaction between immune cells determines immune mediated tumor control.